Alterations & Renovations

Introduction-Alterations and Renovations This is the first resubmission of this CoBRE application that was reviewed in July 2011 receiving a priority score of 6 for the Alterations and Renovations component. The applicants are very appreciative for the insightful comments made by the reviewers. The application is much stronger and improved as a result. Overall, the reviewers scored the Alterations and Renovation plans favorably in regards to: • The application has done an effective effort at linking the proposed improvements to the intended program. Deficiencies are succinctly but adequately described and the need for the improvements is credible. • The proposed renovations to house the three scientific Cores and the administrative office of the Center are well justified. • Space organization concepts for the intended uses are well conceived. • Renovations are relevant to the proposed research. • Cost and suitability appear appropriately justified.